A Feasibility Study of Behavioral Activation in the Rehabilitation of Veterans with Post-TBI Depression

Nearly 400,000 Veterans have been diagnosed with traumatic brain injury (TBI) since 2000, representing
up to 22% of combat casualties. Depression is one of the most prevalent and serious of TBI sequelae. Post-
TBI depression adversely affects rehabilitation, treatment adherence, community reintegration (CR), quality of
life (QOL), social relationships, and caregiver burden. Yet, post-TBI depression remains under-assessed,
undertreated, and under-studied. No clinical guidelines for post-TBI depression treatment exist, and current
treatment is largely based on expert opinion rather than evidence from controlled clinical trials.
A promising therapeutic approach to post-TBI depression is Behavioral Activation (BA), a brief and
pragmatic treatment rigorously tested since the 1970s in clinical trials for depression in diverse clinical
populations. BA can accommodate hallmark deficits of TBI such as deficits in memory, organization,
planning, initiation, emotion regulation, and interpersonal functioning. It can be delivered by professionals
routinely available in VA outpatient rehabilitation services (e.g., occupational therapists, nurses,
psychologists, social workers) and, therefore, can be deployed in rehabilitation settings. The proposed
research will assess the feasibility of a BA protocol adapted for post-TBI depression in an outpatient VA
rehabilitation setting. Specific study objectives are to: (1) assess BA's acceptability to veterans and staff and
other feasibility indices, (2) provide preliminary evidence of participant response in the outcomes of
depressive symptoms, CR, and QOL at the 3-month follow-up interview, (3) develop the BA protocol and
manual to be tested in a larger randomized controlled trial (RCT) in the future, and (4) explore engagement in
activity as the mechanism that underlies BA intervention effects on outcomes.
This feasibility study will enroll 40 male and female veterans receiving care at a VAMC Rehabilitation
Medicine Service and meeting study criteria for TBI and depression. Veterans will be randomly assigned to BA
plus treatment as usual (TAU) or control (TAU). The BA program consists of six sessions delivered over 3
months at the VA (or veterans' homes, if preferred) by an occupational therapist (OT). All veterans are
interviewed at baseline before randomization and 3 months later by a blinded interviewer. Both interviews
assess veterans' depressive symptoms, CR, and QOL, using standardized instruments. Feasibility will be
evaluated in terms of acceptability to veterans and clinic staff, process variables (e.g., retention, study
completion rates), safety, adequacy of eligibility criteria, participant comprehension, and research burden,
using a priori criteria for success. Finally, phone interviews with BA participants and staff will be conducted to
capture their experience with BA. These qualitative and quantitative methods are designed to test the
feasibility of a future RCT, to identify the barriers and facilitators to implementation of BA in the rehabilitation
setting, and to describe patients' experiences and engagement with BA.
This research program has the potential to advance knowledge by identifying a feasible and efficacious
approach to preventing and/or mitigating depression among veterans with TBI, a clinical population at high risk
for depression and its sequelae. Study findings will be used to inform the development of a future RCT
powered to test BA's efficacy in a larger sample of veterans with post-TBI depression.
The research addresses RR&D priorities for research on interventions aiming to improve participation in
society for veterans with psychological health conditions. If BA is shown to be feasible and efficacious, the
research will add an important clinical tool to rehabilitation services that may reduce or prevent depression.
Mitigating depression should in turn facilitate rehabilitation efforts and enhance CR, allowing the veteran to
function more fully in society.

Public health relevance
Depression is the most common psychiatric sequela of traumatic brain injury (TBI) and among its most serious, with wide-ranging consequences including decreased community reintegration and heightened suicide risk. Yet, current treatments are based largely on expert opinion rather than evidence from controlled trials. We propose a feasibility study of a promising intervention for post-TBI depression - behavioral activation (BA) designed for implementation in a rehabilitation setting. In a pilot randomized controlled trial with 40 veterans in VA outpatient rehabilitation care, we will assess the BA intervention's feasibility: acceptability, process, practicality, safety, participant comprehension, research burden, and participant response. This research may add a powerful clinical tool for treating depression in VA outpatient rehabilitation settings, improving access to an important form of care for veterans who suffer with post-TBI depression. Mitigating depression may also facilitate rehabilitation and enhance community reintegration, allowing veterans to engage more fully in society.